Impact of respiratory muscle training and nitrate therapy on exercise tolerance in hypoxia

Project Summary/Abstract
The proposed project investigates the combined effects of respiratory muscle training (RMT) and dietary nitrate
supplementation on exercise performance at sea level and under conditions of simulated moderate altitude.
Recognizing the increased workload on respiratory muscles in various patient populations, which is simulated
by high-altitude ascent, and the resulting diversion of blood flow from locomotor muscles to the diaphragm, this
study aims to address the subsequent reduction in oxygen availability for locomotion, leading to impaired
exercise tolerance. The study will focus on young, healthy adults to explore how RMT and nitrate
supplementation can improve muscle oxygenation, vascular function, and exercise tolerance. This approach is
driven by the need to develop effective interventions that can ultimately enhance physical capacity in various
populations, including critically ill patients recovering from mechanical ventilation and individuals at risk of
acute mountain sickness (AMS) during high-altitude exposure.
Aim 1 will assess the impact of five weeks of RMT on muscle tissue oxygenation and exercise performance at
sea level and simulated moderate altitude (~4000 meters) in young adults. Aim 2 will examine the effects of
five weeks of dietary nitrate supplementation alone and combined with RMT on vascular endothelial function
and exercise performance under similar conditions.
This research will heavily involve undergraduate students, providing them with valuable hands-on experience in
advanced clinical research techniques. The findings are expected to pave the way for future interventions to
enhance physical capacity in ICU patients, reduce the incidence of AMS in high-altitude environments, and
improve exercise performance in various populations. This work will significantly impact patient populations
by laying the groundwork for larger-scale research projects investigating the efficacy of RMT and nitrate-based
therapies in patient populations, including those with chronic respiratory and cardiovascular conditions.
Ultimately, this project aims to develop non-invasive therapies to improve health outcomes related to
respiratory muscle function and exercise tolerance, thereby advancing health science and patient care.

Public health relevance
This research project examines the effects of respiratory muscle training (RMT) and dietary nitrate supplementation on exercise performance at sea level and simulated altitude, particularly focusing on muscle oxygenation, vascular function, and exercise tolerance. The study will evaluate the influence of a five-week RMT on muscle oxygenation and exercise performance, and the impact of dietary nitrate supplementation, alone and in combination with RMT, on vascular function and exercise performance. The outcomes will provide insights into the relationship between respiratory muscle fitness and exercise tolerance, offering potential interventions to enhance exercise tolerance, reduce acute mountain sickness, and increase patient exercise capacity.